PROSTAGLANDIN AND EXERCISE INDUCED INCREASES IN MUSCLE

The purpose of this srudy is to determine the effect of prostaglandins on muscle sympathetic nerve activity (MSNA) during exercise. We hypothesize that ketoprofen, a prostaglandin inhibitor, will attentuate MSNA response to exercise.